Targeting p53 conformational defects to arrest carcinogenesis

PROJECT SUMMARY This supplement extends the work proposed in the parental grant that is focused on targeting p53 protein conformational defects for ovarian cancer prevention and treatment. Here, we will test the effects of the administration of a p53 aggregation inhibitor on cancer development using an in vivo HGSOC model carrying control p53 mutations. We will also investigate whether protein aggregation is a broader phenomenon influencing ovarian cancer cell fitness using organoid models.

Public health relevance
PROJECT NARRATIVE p53 mutations are ubiquitous in ovarian cancer pre-neoplastic cells and tumor cells and can aggregate causing a loss of the tumor suppressive functions of the protein. Here, we will include a crucial in vivo control to confirm whether a solubility transition in p53 marks the progression from benign lesion to ovarian cancer. In addition, we will investigate if protein aggregation in ovarian cancer is a fundamental phenomenon that enhances the fitness of tumor cells when exposed to common physiological stressors.